Digital multi-isotope autoradiography system

Abstract
We request funds for a new autoradiography imager to be located at the Institute for Innovation in Imaging
at Massachusetts General Hospital (MGH). Autoradiography is a powerful analytical tool for the detection and
quantification of isotopes in any tissue sample and is widely accepted as the method of choice for in vivo labeling
and biodistribution measurements. Autoradiography has distinct advantages over in vivo imaging, such as higher
sensitivity, higher resolution, detection of diverse isotopes, and temporal flexibility. The requested
autoradiography provides highly sensitive, real-time imaging, which allows the user to stop the measurement at
the ideal timepoint, optimizing experimental outcomes. Currently, investigators use a screen-based
autoradiography instrument that is no longer supported by the vendor and requires third party, non-ideal screens.
The dual mission of the Institute for Innovation in Imaging is technology development and translational
research involving advanced imaging techniques such as magnetic resonance imaging (MRI), positron emission
tomography, optical imaging, and ultrasound. The Institute for Innovation in Imaging, the adjacent Martinos
Center, and MGH broadly have a strong positron emission tomography imaging and probe development
program, represented by the research projects in this application. The proposed equipment would significantly
strengthen this research effort though a unique, complementary imaging pathway.
The requested instrumentation will be administered as a shared resource for the Institute for Innovation in
Imaging, the larger MGH research community, as well as other institutions in the greater Boston area. The
Principal Investigator and Advisory Committee will ensure both equitable and cost-effective operation of this
system. The acquisition of this real-time autoradiography equipment will establish the only instrument in the
greater Boston area capable of making these measurements that are available to academic researchers, and
the Institute for Innovation in Imaging is strongly positioned to host this unique capability. We expect the proposed
instrument will play an essential role in driving many new discoveries pertaining to a host of medically related
issues including cancers, lung diseases, immunology, neurological diseases, heart diseases, liver diseases,
stroke, and neural plasticity.

Public health relevance
Project Narrative Funds are requested to replace an existing shared screen-based autoradiography imager with real-time detection for high sensitivity analysis that will allow quantification and distribution of any radio isotope. The analyses enabled by this instrument will underpin NIH-funded research projects in cancer, heart disease, neurological diseases, immunology, chronic liver disease, stroke, neural plasticity, lung disease, and imaging probe development.